Origin of Cortical Species-specific Distinctions

SUMMARY STATEMENT on which Merit has been based
The major goal of this Merit Award was to elucidate the mechanisms of development of the
primate cerebral cortex that are most relevant to humans but cannot be adequately studied
experimentally in non-primate species. We proposed to perform unique research on
molecular and cellular mechanisms of cortical development with focus on association
areas and particularly the prefrontal cortex (PFC) that are linked to major cognitive
disorders and addiction susceptibility but cannot be studied adequately in human. Thus, in
the original application we proposed to perform multidisciplinary experimental research in
non-human primate (NHP) Macaques Rhesus within the scope of 3 Specific Aims that
were approved with high rate by the Study Section: Aim 1: deals with genetic determinants
of early cortical expansion and functional analysis of proliferation/differentiation of radial
glial cells (RGCs) in NHPs. Aim 2 deals with commitment of RGCs leading to laminar
specificity of neuro- and gliogenesis and region-specific contributions of Hopx+ bRGC to
neuro- and glio-genesis analysis in fetal macaque. Aim 3: deals with the role of neuropil
and white matter growth in cortical expansion and gyrification and genetic basis of the
cortical neuropil explosion and role of incoming/outgrowing axon tracts and emerging
sulci/gyri in NHP.

Public health relevance
The identification of molecular and cellular mechanisms involved in primate cortical development and evolution is essential if we are to understand the origins of, and devise prevention and/or treatments for, genetic and environmentally caused cortical abnormalities in humans. Thus, the expected set of unique data are not only of theoretical significance, but also of considerable clinical importance as they may be relevant to disorders of our highest cognitive functions as well as our response to drugs of therapy and abuse.